Thyroid hormone mediated reprogramming of the basolateral amygdala by adolescent social deprivation

PROJECT SUMMARY
Social disconnection in humans, particularly during adolescence, is associated with substance use disorder
vulnerability. In mice, adolescent social isolation profoundly alters reward processing in adulthood; increasing
the preference for drugs of abuse, enhancing associative learning, altering dopaminergic signaling and
transcription within the BLA and extended reward circuitry. Intriguingly, these phenomena are all also associated
with thyroid hormone signaling. Further, dysregulation of thyroid hormone in early life is associated lifetime risk
for reward-related mood disorders and altered development of monoaminergic systems. In adults, thyroid
hormone dysregulation is associated with substance- and alcohol use disorders. Therefore, we propose that the
persistent impacts of adolescent social isolation result from transient dysregulation of thyroid hormone signaling
during the sensitive period of adolescence. Thyroid hormones, when bound to their receptors, are transcription
factors that mediate various epigenetic processes and regulate gene expression. Aberrant thyroid hormone
signaling at critical developmental periods persistently alters transcription in other tissues through epigenetic
reprogramming of thyroid hormone sensitive genes. Despite its critical role in neurodevelopment and its link to
substance use disorder, the consequences of thyroid hormone dysregulation in adolescence, a key period for
reward circuitry development and substance use disorder vulnerability, is virtually unknown. Our preliminary data
suggest that circulating thyroid hormones and expression of its receptors are transiently disrupted in adolescence
by social isolation and this is associated with enhanced expression of GABAergic neuronal markers in the adult
basolateral amygdala (BLA), a key reward-related brain region
Here, we will test the hypothesis that thyroid hormone is critical for development of the basolateral amygdala
(BLA) during adolescence and that isolation-induced disruptions to the thyroid hormone system result in lasting
epigenetic reprogramming of the reward circuitry to increase cocaine sensitivity. First, we will determine how
adolescent social isolation impacts thyroid hormone-mediated transcription in the BLA (Aim 1). Then we will
determine if thyroid hormone dysregulation induced by adolescent isolation disrupts cell-type specific
transcriptional profiles within the BLA (Aim 2). Finally, we will disrupt thyroid hormone receptor beta levels
specifically during adolescence to determine its role in reward-related behavior in (Aim 3). Together, these
foundational studies will establish a role for thyroid hormone-mediated programming of the BLA and uncover
novel mechanisms of isolation-induced reprogramming of SUD vulnerability during adolescence - an endpoint
that has become even more urgent given the known reductions in social interactions due to the mitigation of
Covid-19 for the current generation of adolescents.

Public health relevance
PROJECT NARRATIVE Adolescence is a period of heightened sensitivity to peer-directed social interactions and negative peer interactions or social disconnection during this time are risk factors for substance use disorder (SUD). Loneliness is associated thyroid hormone dysregulation in humans and adolescents experience more loneliness/social disconnection than any other group, which was only exacerbated by the mitigation of Covid 19. Here we address the urgent need to better understand the mechanisms underlying the enduring impacts of social experience on the adolescent brain by investigating how social isolation dysregulation of thyroid hormone signaling during adolescence serves as an epigenetic switch underlying adolescent brain development and vulnerability to SUD with the goal of identifying critical windows of intervention and new therapeutic targets for SUD.